Cell therapy for GvHD

Abstract.
Hematologic malignancies are often treated with allogeneic hematopoietic stem cell transplantation (HSCT).
However, HSCT is complicated by graft-vs-host disease (GvHD), a severe, potentially lethal complication
initiated when donor alloreactive T cells attack host cells and organs. Despite the administration of prophylactic
regimens for aGVHD as standard pre-transplantation therapy, up to 60% of these patients develop aGVHD of
grade II or higher, and require additional immunosuppressive intervention. Thus, there is an urgent need to
improve pre-transplantation therapies to prevent aGVHD. We identified a probiotic exopolysaccharide (EPS)
that induces tolerogenic dendritic cells (DCs) that inhibit T cell proliferation, and we found that EPS-treated
human DCs (EPS-DCs) both inhibited T cell proliferation in mixed lymphocyte reactions, and significantly
increased survival of humanized NSG-HLA-A2 mice after transplantation with human peripheral blood
mononuclear cells (hPBMC). The data indicate that a cell-based therapy using EPS-DCs can mitigate aGvHD,
and the goal of this grant is to optimize the EPS-DC dosage for maximum protection from GvHD, and to
determine the molecular mechanism by which these EPS-DCs inhibit proliferation of alloreactive T cells both in
vitro and in vivo. These studies will provide a novel cell-based therapy for preventing GvHD in patients
receiving HSCT. This cell therapy will be translatable to humans because large numbers of EPS-DCs can be
generated and frozen in bulk and used as “off the shelf” treatment, for all patients, independent of MHC types.

Public health relevance
Project narrative Graft versus host disease (GvHD) is a frequent outcome of hematopoietic stem cell transplants used to treat hematologic diseases, such as leukemia. We have identified a means of reducing GvHD by administering cells pre-treated with a purified bacterial molecule, exopolysaccharide (EPS). EPS is non-toxic and the goal of this grant is to use a humanized mouse system to optimize treatment and to determine how EPS-treated cells inhibit GvHD, leading to new drugs to prevent GvHD in humans.